Gene Regulatory Networks in Development and Physiology

What we eat impacts how our physiology and affects our propensity to get diseases such as obesity
and diabetes. The bacteria that inhabit our intestine, our gut microbiota, greatly influence numerous
physiological traits, including our nutritional intake, and also affect our response to therapeutic drugs.
A major goal of biomedical research is to uncover the interplay between dietary nutrients and
metabolites plus resident microbiota and the subsequent effect on our physiology. In addition, a major
challenge is to dissect the mechanisms by which bacteria modulate the response to therapeutic drugs.
We have developed an innovative interspecies systems biology model of the nematode C. elegans and
its bacterial diet to address these questions. We have used this model to uncover bacterially derived
micronutrients and metabolites that affect gene expression, development and fertility in the worm, and
to identify a C. elegans metabolic regulatory network that mediates the response to bacterial nutrients.
In addition, we have discovered mechanisms by which bacteria modulate the C. elegans response to
several chemotherapeutic drugs. In the next project we will use our demonstrated strength to
investigate the effects of bacteria both broadly, in systems-level surveys and screens, and deeply with
targeted mechanistic experiments. We will connect bacterial metabolism to host physiology and gene
expression as well as the response to a variety of therapeutic drugs. The data obtained will provide an
important stepping stone toward understanding how the microbiota can modulate human physiology in
terms of nutrition and the response to xenobiotic compounds such as therapeutic drugs. This work,
therefore, has long-term implications for nutrition, toxicology, as well as personalized and precision
medicine.

Public health relevance
The bacteria that inhabit our body, or our microbiota, help to digest our food, but can also modulate our response to therapeutic drug treatment. We have developed the nematode C. elegans and its bacterial diet as an interspecies model system to rapidly gain both broad systems-level and deep mechanistic insights into the connections between diet, physiology, drug response, gene expression and metabolism. We will continue to use the model system to dissect the mechanisms by which bacteria and nutrients contribute to a variety of physiological traits, gene expression and diseases.